The Role of CXCL9 and CXCL10 in Adverse Cardiac Remodeling Following Streptococcus pneumoniae Infection

PROJECT SUMMARY
This NIH F30 application describes a plan for mentored research and career development for the PI, Daniel
Minassian. Community-acquired pneumonia (CAP) has increasingly been recognized as a significant risk factor
for MACE such as new or worsening heart failure, arrhythmia, and myocardial infarction in hospitalized patients.
Streptococcus pneumoniae (Spn) is the leading cause of CAP and models of Spn-induced chronic heart failure
have been well-established by the sponsor of this proposal (Dr. Orihuela) in non-human primates and mice. The
mechanisms through which Spn infection leads to heart failure are unclear, as it occurs despite appropriate
antibiotic therapy, mirroring what is observed clinically; patients who survive treatment for pneumonia are at
elevated risk for MACE even 10 years following admission to the hospital. Our preliminary data suggests that
post-infection inflammation is causative of cardiac dysfunction as mice treated with a combination of steroids
and antibiotics do not suffer reduced ejection fraction, and mice lacking T cells and B cells show a strong trend
toward reduced or no chronic cardiac dysfunction following infection. Analysis of RNAseq data obtained from the
hearts of mice acutely infected with Spn suggests that the CXCR3 ligands CXCL9 and CXCL10 are particularly
upregulated; we have confirmed their production in reporter mice. These chemokines are highly pro-inflammatory
and it is the objective of this proposal to determine how CXCL9 and CXCL10 contribute to subsequent heart
failure. We hypothesize that CXCL9/10 signaling following pneumonia initiates an inflammatory cascade which
leads to chronic inflammation and adverse cardiac remodeling. We will test this hypothesis by examining the
impact of Spn infection on CXCL9 and CXCL10 production in the heart (Aim 1) and determining the role of
CXCL9/10 signaling in modulating cardiac inflammation and long-term fibrosis (Aim 2). Aim 1 will primarily be
accomplished through single nuclear RNA sequencing (snRNAseq) of hearts from infected or antibiotic-treated
mice at different times. Aim 2 will be accomplished by blocking CXCL9, CXCL10, and their cognate receptor,
CXCR3, through neutralizing antibodies or genetic knockouts and assessing cardiac inflammation through flow
cytometry and cardiac damage through echocardiography, histopathology, and relevant biomarkers. All
experiments will be performed at the highly funded University of Alabama at Birmingham which is equipped with
faculty expertise in Spn and cardioimmunology and all the tools necessary for this proposal. Included in the
training plan for the PI are experiences that will support Daniel’s career and professional development, such as
1) rigorous scientific training in the application of advanced flow cytometry, snRNAseq, and next-generation
sequencing analysis; 2) presentation of findings at national conferences; 3) continuing clinical education. This
proposal drives the development of skills supporting the PI’s future career as a cardiologist-scientist studying
how immunological and infectious insults drive the development of heart failure.

Public health relevance
PROJECT NARRATIVE Community-acquired pneumonia (CAP) is a significant risk factor for major adverse cardiac events (MACE) as nearly one-third of patients hospitalized for CAP will experience new or worsening heart failure, arrhythmia, or myocardial infarction. The overall goal of this project is to understand how induction of the pro-inflammatory chemokines CXCL9 and CXCL10 by the leading cause of CAP, Streptococcus pneumoniae, leads to cardiac inflammation and adverse remodeling. The findings from this project will inform efforts to treat pneumonia- induced cardiac inflammation and prevent MACE.